Phenomaster NG Mouse Metabolic Phenotyping System

ABSTRACT
In this S10 application, funds are requested to purchase a new system for mouse metabolic phenotyping to
serve the many researchers interested in metabolism at Washington University in St. Louis. We are seeking
to acquire a Phenomaster Next Generation (NG) mouse metabolism phenotyping system with modules for
measuring physical activity, food intake, oxygen consumption, carbon dioxide production, and other metabolic
parameters concurrently in sixteen individual cages. Moreover, this system will also provide two motorized
treadmills for measuring these parameters during exercise challenges. Lastly, the new system will be
enclosed in an environmental chamber to control light cycles, prevent environmental stressor exposure, and
control the temperature in a range from 3-30ºC. We have identified more than a dozen Washington University
faculty members who are NIH funded and will be major users for this system. In addition, several minor users
were also identified. These faculty members are appointed in a variety of departments across Washington
University, which illustrates the cross-disciplinary interest in metabolism at the institution and also
emphasizes the collaborative nature of our university. The PhenoMaster NG system would be housed in the
Animal Models Research Core, which serves both the Diabetes Research Center and Nutrition Obesity
Research Center at Washington University. Currently, this core uses a PhenoMaster system that is several
years old, employs antiquated technology, comprises only eight cages, and currently is reserved several
months in advance with users waiting to gain access. The new system would alleviate much of this wait time
and with the technologic advances it provides, would improve rigor and reproducibility of the experiments
conducted in this system. The additional modules (treadmills and 13CO2 sensors) included in the system will
also provide new experimental opportunities and endpoints for rigorous characterization of metabolic
phenotypes. Successful acquisition of the PhenoMaster NG will enhance throughput, accuracy, and precision
of an existing metabolic phenotyping facility that serves multiple NIH-funded investigators across campus.

Public health relevance
Project Narrative We hope to obtain a new PhenoMaster NG system for comprehensive mouse metabolic phenotyping at Washington University in St. Louis. This system will augment an already successful metabolic phenotyping facility and enhance the rigor and sophistication of the studies conducted by NIH-funded investigators to characterize metabolism in pre-clinical models.